Validation of APT101 for the Treatment of Systemic Sclerosis-Associated Interstitial Lung Disease (SSc-ILD) in an Aging Murine Model

Abstract
Systemic Sclerosis (SSc) is a rare autoimmune disease which carries the highest risk of mortality
of all connective tissue diseases. Two major subgroups of SSc exist: limited cutaneous
scleroderma characterized by dermal fibrosis, and diffuse cutaneous scleroderma
characterized by fibrosis rapidly progressing to internal organs such as the lungs, kidneys, and
heart. Diffuse cutaneous SSc is characterized by vascular dysfunction that initiates a cascade
of inflammation and autoimmune responses leading to progressive organ fibrosis. Morbidity in
SSc is largely driven by the development of SSc associated ILD (SSc-ILD) with fibrosis in the
lungs. Pulmonary fibrosis is now the leading cause of death in patients with SSc-ILD.
It is well established that vascular endothelial dysfunction is an important component and
precursor of SSc-ILD. The apelin/apelin receptor (APJ) signaling axis on endothelial cells has
been implicated as a crucial hub for both vascular development and repair. APJ-dependent
signaling has also been shown to be critical for resolution of acute lung injury. Aging and injury
have both been shown to confer reductions in endogenous apelin/APJ signaling, emphasizing
reduced capacities for vascular repair and regeneration with persistent fibrosis in aging models
of injury. While our foundational studies confirm the novel potential for selective APJ agonism as
a therapeutic strategy, further investigation into (1) comparative efficacy in clinically relevant non-
resolving aging murine model of pulmonary fibrosis and (2) the mechanistic effect of APJ
agonism on underlying endothelial function in the fibrotic lung are necessary to de-risk clinical trial
outcomes for this novel anti-fibrotic strategy in SSc-ILD. Studies with aging models of pulmonary
fibrosis are critical for testing novel therapeutic strategies.
Our preliminary results demonstrate that therapeutic treatment with APJ agonist, APT101,
reduces lung fibrosis in young mice after bleomycin challenge. We hypothesize that selective
therapeutic agonism with APT101 will promote vascular repair and regeneration following lung
injury, resulting in less vascular permeability and reduced lung fibrosis. To better recapitulate
human disease, we will use a non-resolving model of pulmonary fibrosis (bleomycin in young vs.
aged mice) to demonstrate that therapeutic administration of APT101 limits fibrosis through
reductions in vascular permeability and improved endothelial cell repair and regeneration
in vivo (Aim 1). We will also validate the translational potential of APT101 using human lung
endothelial cells in vitro to assess whether selective APJ signaling improves endothelial cell
regenerative capacity (Aim 2). These STTR Phase I studies will help de-risk APT101 as it moves
forward towards clinical translation.

Public health relevance
Project Narrative Systemic sclerosis (SSc), or Systemic scleroderma, is a progressive, disabling, and often deadly disease. SSc-associated interstitial lung disease (SSc-ILD) drives SSc morbidity and is the leading cause of death for SSc patients. Aging is a major risk factor in SSc-ILD. APIE Therapeutics is developing a novel drug portfolio with the potential to repair and reverse vascular damage caused by systemic scleroderma, thus improving prognosis and survival, with a focus on the affected aging population.